Adapting a low-cost intimate partner violence (IPV) and mental health response intervention for women in informal settlements in Kenya

PROJECT SUMMARY/ABSTRACT
The purpose of this International Research Scientist Development Award (K01) is to provide the candidate with
the training and expertise needed to transition into an independent global health researcher with expertise in the
science of violence- and health-related intervention in informal settlements. Globally, 30% of women have
experienced intimate partner violence (IPV). Prevention and response to IPV is critical; yet few interventions
have been adapted for residents of informal settlements. Currently, 56% of the 3 million residents in Nairobi, the
capital city of Kenya, live in informal settlements, and this population is likely to double by 2050. Research carried
out in 2012 in Kibera, the largest informal settlement in Nairobi, reported that 85% of women have experienced
IPV in their lifetime and a 2018 study reported that 66% of women in similar Nairobi settlements experienced
IPV in the past year. Women experiencing IPV are more likely to also experience depression, anxiety, and post-
traumatic stress. In 2014, Kenya identified reduction of and response to violence against women (VAW) as a
priority health area in national policies and strategic plans; yet, no screening or response protocols have been
adopted in clinics in informal settlements for IPV survivors. The aims of this study are, therefore, to: 1) identify
potential facilitators and barriers to screening and intervention for IPV and related mental health challenges in
healthcare settings in informal settlements in Kenya; 2) combine an IPV (WINGS) and mental health (PM+)
response intervention and adapt the combined (WINGS+PM+) intervention for use in existent healthcare settings
in informal settlements in Nairobi; and 3) pilot test the adapted WINGS+PM+ intervention through a randomized
control trial with 130 women to assess the safety, feasibility, and acceptability of WINGS+PM+ versus PM+-only
as the foundation for a low-cost IPV services package that can expand services to women experiencing IPV in
informal settlements. The proposed career development plan has been designed to augment the applicant's
experience researching VAW and women's health in informal settlements in Kenya and enable her to: 1) gain
research skills in the design and adaptation of violence- and health-related interventions, with an emphasis on
low-cost interventions that can be carried out by lay community members in healthcare settings in informal
settlements; 2) obtain methodological expertise in the design, adaptation, delivery, and assessment of feasibility
and acceptability of interventions; 3) cultivate important relationships with global health experts, intervention
scientists, and healthcare providers in informal settlements in Kenya and East Africa, and 4) increase her
professional skills for a successful independent global health research career, including grantsmanship,
manuscript writing, and collaborative interdisciplinary and international research. The training goals will be
achieved through didactic courses, specialized workshops and seminars, hands-on research, and mentoring
from an interdisciplinary team of experts in both the U.S. and Kenya. The research findings and methodological
skills to be gained from this IRSDA (K01) have important applicability for health research in Kenya.

Public health relevance
PROJECT NARRATIVE Global estimates of violence against women (VAW) suggest that one in three women will experience intimate partner violence (IPV) in their lifetime and that these women are much more likely to experience psychological distress, but recent research suggests that closer to 85% of women in informal settlements in Nairobi, the capital city of Kenya, experience IPV in their lifetime. Health polices in Kenya call for strategies to respond to and reduce VAW and co-occurring mental health disorders; thus, the proposed project will: 1) adapt a combined IPV screening, brief intervention and referral to treatment and mental health intervention (WINGS+PM+) that can be carried out by lay community health workers as a foundation for a potential low-cost essential services package for women experiencing IPV and related mental health challenges in informal settlements in Kenya and 2) assess the feasibility, safety, and acceptability of the intervention in an existent healthcare setting in Kibera—a large informal settlement in Nairobi. This project advances IPV response intervention by providing a low-cost combined IPV and mental health response intervention that has the potential to expand critical services to women experiencing IPV in informal settlements—women who are more likely to be experiencing IPV and less likely to have access to these services—and to help reduce IPV and psychological distress for these women.